Computationally designed, small molecule-responsive cell receptors for treating solid tumors

Project summary
Chimeric antigen receptor T (CAR T) cell cancer therapies are thwarted by the difficulty of targeting antigens on
solid tumor cells. Archetypal CAR-binding tumor cell surface proteins are not unique to tumor cells and can also
be found on host cells. Further, solid tumor cells express these antigens at different levels, even within one
tumor. In this complex and immunosuppressive environment, the standard CAR T strategy of targeting tumor
cell surface proteins is insufficient and results in off-tumor CAR T cell binding and activation, leading ultimately
to T cell exhaustion. To solve this problem, we propose a modular, logic-gated split CAR format that can respond
to the combination of tumor cell surface proteins and metabolites enriched in the TME by clustering intracellular
domains to activate T cell signaling pathways. This format allows for CAR T cells to activate the production of
cytokines, cell adhesion proteins, and other tumor destruction modalities only after localizing to the TME.
The proposal has three Aims. In Aim 1, we will establish the split CAR format for targeting solid tumors, which
includes two synthetic receptors that are each fused to compatible intracellular co-stimulatory domains and
cytokine engagement domains. One receptor, engineered from the blueprint of the human GABAB G-protein
coupled receptor (GPCR), will function as a small molecule “sensor receptor”; its “partner receptor” will bind to a
tumor cell surface protein as well as the agonist-bound form of the first receptor. When the paired receptors are
bound to the extracellular agonist and the tumor cell surface protein, their co-stimulatory domains will localize
together inside the cell to activate NFAT signaling in Jurkat reporter cells. In Aim 2, simultaneously with Aim 1,
we will adapt the sensor receptors to bind and respond to TME metabolites by developing a computational
protein design protocol to reengineer their binding sites. We will screen the designed protein library to isolate
TME metabolite-responsive CARs and tune their binding for physiologically relevant metabolite concentrations
using established experimental protein engineering methods. In preliminary data, we have prototyped a
computational design strategy and TME sensor receptor format using homologous model receptors. In the final
Aim, we will combine the redesigned TME metabolite receptors with a HER2+ breast cancer-specific partner
receptor to deploy the split CARs in primary human T cells co-cultured with HER2+ breast tumor cells and monitor
T cell activation and tumor cell lysis as a proxy for CAR T efficacy. Following the successful application of our
CAR T strategy in cell culture as described in this proposal, we will next collaborate with leading T cell biologists
at our university to deploy the receptors in a preclinical humanized mouse model to evaluate CAR T efficacy in
vivo. Our proposed CAR T cell therapy platform is unique in its capacity to bind to a both an endogenous TME
metabolite and a tumor cell surface marker to elicit a programmable intracellular T cell activation response.

Public health relevance
Project narrative Despite the success of chimeric antigen receptor T (CAR T) cell therapies in treating lymphomas, it remains challenging to target solid tumors safely and effectively without impacting healthy tissues. However, targeting CAR T cells to metabolites that are enriched or depleted in the TME, in addition to tumor cell surface antigens, may improve the efficacy of this approach for solid tumors. In this project, we target combinations of tumor- specific antigens and TME metabolites by engineering modular CARs that link the extracellular detection of these ligands with the activation of T cell signaling pathways for tumor destruction.